Staphylococcal pathogenesis

In FY 2023, we continued our investigation of virulence factors that contribute to Staphylococcus aureus pathogenesis and immune evasion. The focus is on understanding which factors define the virulence potential of highly virulent MSSA and MRSA clone. We are also investigating biofilm-associated infection by staphylococci and its molecular basis.
Much of our work is currently still focussed on phenol-soluble modulins (PSMs), toxins that we discovered in 2007. We collaborate with a series of researchers in different fields, analyzing the contribution of PSMs to different phenotypes. Current efforts in our own lab are aimed at understanding the mechanism of the PSM exporter, the function of PSMs as signals of staphylococcal invasion, and the involvement of PSMs and quorum-sensing in staphylococcal sepsis.
We are also collaborating with several institutions, including Shanghai Renji Hospital (Dr. Min Li's group) on other bacterial pathogens and infections.